MerTK in NASH-related liver fibrosis

Project Summary/Abstract
Nonalcoholic steatohepatitis (NASH) has emerged as the leading cause of chronic liver disease worldwide,
with liver fibrosis being the most important predictor of liver failure in NASH. The lack of definitive mechanisms
of NASH progression, particularly fibrosis limits the design of mechanism-based therapeutic targets and
treatment options. Several independent human GWASs have identified MERTK as a risk factor for liver fibrosis.
However, the mechanisms of MerTK-mediated liver fibrosis are not completely understood. The overall
objective of this proposal is to understand mechanisms of MerTK-induced NASH fibrosis and shed new light on
novel therapeutic strategies to prevent NASH progression. Using a diet rich in fructose, palmitic acid, and
cholesterol (FPC) developed by our group that promotes human-like NASH pathologic features in mice, I found
that genetic targeting of MerTK decreases NASH fibrosis and that MerTK-mediated ERK activation increases
the expression of TGFβ1 in macrophages (Ms), and that MerTK activation increases AKT activity and
collagen gene expression in hepatic stellate cells (HSCs). Moreover, I made an important discovery that
MerTK cell-surface cleavage is decreased in fibrotic livers. Indeed, I found that all-trans retinoic acid (ATRA), a
major active metabolite of retinol found in healthy liver, induces MerTK cleavage in both Ms and HSCs.
Accordingly, I propose that ATRA-induced MerTK cleavage protects against NASH fibrosis but this cleavage is
hampered in fibrotic liver due to the loss of retinoids, leading to the progression of NASH. I propose 3 aims to
study the mechanisms of MerTK-induced NASH fibrosis. Aim1 will explore the hypothesis that MerTK in Ms
contributes to NASH fibrosis. Mertkfl/flLysmCre+/- and the littermate control mice fed the FPC diet will be used to
study the role of M MerTK in NASH fibrosis. I will determine whether M MerTK-induced NASH fibrosis is
through the ERK1/2-AP1-TGFβ1 pathway. Aim2 will investigate the hypothesis that MerTK in HSCs
contributes to NASH fibrosis. Mertkfl/flLratCre+/- mice fed the FPC diet will be used to study the role of HSC
MerTK in NASH fibrosis. I will determine whether HSC MerTK-induced NASH fibrosis is through activating
PI3K/AKT. Aim 3 will explore the hypothesis that suppressing MerTK cleavage promotes NASH fibrosis. I will
determine the association of fibrosis stages with hepatic ATRA and MerTK cleavage and determine whether
ATRA-induced MerTK cleavage is through activating P38 and the MerTK cleaving enzyme, ADAM17 in vivo.
This research will be accomplished in the setting of a comprehensive career development program designed to
provide me with the skills needed to achieve my career goal as an independent scientist in the field of liver
diseases. During the K99 phase, I will continue to gain expertise in molecular, cellular and biochemical
approaches to study NASH fibrosis at Columbia University. An advisory committee of established scientists in
the fields of NAFLD/NASH, liver fibrosis, HSC activation, and translational science will guide me in the steps
towards successful transition to scientific independence over the course of the award period.

Public health relevance
Project Narrative Nonalcoholic steatohepatitis (NASH) is emerging as the leading cause of chronic liver disease worldwide. Due to the major gaps in understanding the mechanisms of NASH progression, particularly fibrosis, there are no FDA-approved drugs to treat NASH. Given that GWASs have identified MERTK as a risk factor for liver fibrosis in NASH patients, this proposal aims to explore mechanisms of MerTK-induced liver fibrosis in NASH and will shed new light on therapeutic strategies to curtail and reverse NASH fibrosis.